CCTN-PHARMACOKINETIC / PHARMACODYNAMIC EVALUATION OF LEVONOGESTREL BUTANOATE FOR FEMALE CONTRACEPTION

There is a demand for estrogen-free contraception m order to reduce the risk of venous thromboembolism (VTE), particularly for obese women . A ne,., long-acting formulation of levonorgestrel butanoate (LB) delivered by injection has been developed. Levonorgestrel (LNG) has a long history of clinical use in a variety of contraceptives (pills, intrauterine devices, and implants) and its efficacy and safety arc well recognized. The Eunice KenJ1edy Shriver National Institute of Child Health and Human Development (NICHD) has a mission to develop safe and effective contraceptives for women, including obese women. Obesity is tl1e number one public health issue facing the US population and is an independent risk for venous thromboembolism (VTE). Therefore, there is a public health need to develop effective contraception for obese woman that does not increase the risk of VTE. One Food and Drug Administration (FDA) -approved contraceptive method is the progestin-only pill (POP) or so-called mini pill, which is used mainly by lactating women only for several months and requires strict adherence to taking the POP at the same time every day. A long-acting inject able form of LB that is estrogen-free will provide a regimen that is easier to follow than a POP and have a theoretically lower risk of VTC especially for obese women In order to provide preliminary evidence that LB could be effective for contraception, a clinical trial will be conducted in the NICHD Contraceptive Clinical Trials Network (CCTN). The proposed study will be conducted m \\Omen of reproductive age in order to evaluate pharmacokinetics , the mechanisms of contraceptive efficacy, and safety of this new contraceptive. The enrolled subjects will receive LB via intramuscular and subcutaneous routes of inject ion. The Recruitment will include enrollment of approximately 50% of subjects with BMI >=32 kg/m2 but less than 40 kg/m2